Neuroanatomic and Functional Characterization of Cerebellar Circuits Mediating Ingestive Behaviors

Project Summary/Abstract
Understanding the interconnected web of brain circuits that regulate body weight (fat) is vital for the prevention
and treatment of obesity. The goal of this proposal is to establish a novel role for the cerebellum in feeding
behaviors related to obesity. The vast computational power of the cerebellum (>1/2 of all neurons in the human
brain are cerebellar granule cells) has traditionally been considered in relation to movement. However, mounting
evidence suggests that cerebellar machinery for learning and predictive control operates across a much wider
domain: ranging from autonomic functions to cognitive and motivated behaviors. Guided by our recent finding of
a specific region of the mouse cerebellum that potently drives ingestive behavior, the proposed experiments
leverage state-of-the-art methods for mapping, monitoring, and manipulating neural circuits in mice to elucidate
cerebellar roles in feeding behavior. The proposed studies will lay the groundwork for imputing a vital role of the
cerebellum in optimizing feeding behaviors in the context of extant physiological and environmental conditions.

Public health relevance
Project Narrative Understanding the complex web of brain regions that control feeding behavior is critical for understanding and treating obesity. Although typically considered in relation to motor control, converging lines of evidence suggest that the cerebellum--an ancient brain region containing >1/2 of all neurons in the human brain and possessing powerful mechanisms for learning--also plays an important role in cognition and motivated behavior. The goal of this proposal is to identify a potentially vital role for the cerebellum in the adaptive regulation of feeding behaviors related to obesity.